Functional characterization of viral non-polyadenylated sequences that enable mRNA stability and translation

PROJECT SUMMARY/ABSTRACT
Eukaryotic mRNAs typically have a 5’ cap and 3’ poly(A) tail that protect the ends from degradation. In
addition, the cap and poly(A) tail are recognized by specific RNA binding proteins (eIF4E and poly(A) binding
protein [PABP], respectively) that help the mRNA form a closed loop that promotes efficient translation. Many
viruses analogously ensure their mRNAs end in poly(A) tails, but there are thousands of other viruses,
including Flaviviridae, Bunyavirales, Reovirales, and Nodaviridae, that solely generate non-polyadenylated
mRNAs. A handful of these non-poly(A) mRNAs are known to bind PABP, while others instead use viral
proteins to bridge the non-poly(A) end to proteins bound to the cap, enabling the mRNA to adopt a closed loop.
However, key molecular details of how the vast majority of viral non-poly(A) 3’ ends, including from
Bunyavirales, enable mRNA stability and translation remain unknown. Addressing this gap will reveal
critical insights into molecular mechanisms of pathogenesis and identify novel avenues for developing highly
specific antivirals. Bunyavirales is a large order of single-stranded, segmented negative-sense RNA viruses
that can cause serious human disease, yet there are no effective therapies or vaccines. They generate
capped, non-poly(A) mRNAs and the exact 3’ ends of some of these transcripts were mapped decades ago.
Their regulation is independent of PABP, but little else is known about how exactly these 3’ ends are stabilized
or enable translation. This is in part due to a lack of efficient methods for generating and manipulating non-
poly(A) mRNAs in cells. We have now overcome this major obstacle by repurposing a unique cellular process
discovered in our lab (3’ end processing of the noncoding RNA MALAT1) into a novel expression method that
efficiently and easily generates non-poly(A) mRNAs that precisely end in any sequence of interest. Here, we
will take advantage of this new method to characterize the key minimal sequences and underlying molecular
mechanisms of how select viral non-poly(A) mRNAs are stabilized and translated. We hypothesize that many
of these non-poly(A) sequences fold into structures that enable interactions with RNA binding proteins distinct
from PABP, thereby enabling the viral mRNAs to be subjected to unique regulatory strategies that may
promote their own expression over host mRNAs and/or be targetable by therapeutics. In Aim 1, we will define
in detail how non-poly(A) 3’ ends from exemplar bunyaviral mRNAs enable mRNA functionality. The minimal
functional sequences and their protein binding partners will be identified, thereby revealing new paradigms of
bunyaviral post-transcriptional gene regulation. In Aim 2, we will perform a novel massively parallel reporter
assay to screen non-poly(A) sequences from the 3’ ends of a variety of viral mRNAs in order to rapidly identify
those that most efficiently stabilize a reporter mRNA and enable robust translation. These collective efforts will
reveal critical insights into how viruses ensure their mRNAs are hyper-stable and translated, which will help
guide the development of novel antivirals and mRNA-based therapeutics with higher expression and efficacy.

Public health relevance
PROJECT NARRATIVE Messenger RNAs in human cells typically end in a poly(A) tail that controls their fate and function, including their ability to be used as templates for making protein. In contrast, many viruses generate RNAs that lack a poly(A) tail yet are still used to make protein, indicating these viral RNAs are regulated via distinct mechanisms that remain poorly characterized. Addressing this knowledge gap will provide important insights into how viruses cause disease as well as identify novel avenues for the development of highly specific antiviral therapies.